Development of a photothermal stimulator array for controlled neuron stimulation

Project Summary/Abstract
Retinal degenerative diseases, such as retinitis pigmentosa (RP) and age-related macular degeneration
(AMD), affect more than 10 million Americans. Unfortunately, many patients eventually suffer vision loss due to
no available therapeutic cure for these diseases. Retinal prosthesis is the only available option to make
artificial interfaces to restore a damaged neural path. Electrical stimulation-based retinal prostheses have been
most widely used due to their conceptual simplicity. However, it faces many hurdles due to complex signal
interfaces, especially for high spatial resolution. A novel approach based on the principle of stimulating
neuronal cells with a direct optical-induced thermal signal is introduced to potentially offer more advantages
over the electrical stimulation approach. However, the concept is relatively new, and necessary engineered
means should be developed to translate this approach to retinal prostheses. The goal of the proposed
research is to create a two-dimensional array of photothermal pixels, of which the thermal stimulation is directly
controlled by incoming light images. Based on the optical stimulation approach, this will address many
challenges that the current electrical stimulation face, especially for large area stimulation. Successful
completion of the proposed research will represent a revolutionary advance on the photothermal-based
stimulation method and open a new opportunity of using photothermal stimulation in retinal prostheses.

Public health relevance
Project Narrative Many patients with retinal degenerative diseases are eventually suffering vision loss due to no therapeutic treatment. While electrode-based retinal prostheses have been most widely used to restore photoreceptor functions, they face many hurdles when this method is applied to a high-resolution neural stimulation. Based on direct optical stimulation, the proposed thermal stimulator will simplify its safe implementation and significantly improve spatial and temporal resolution over the current methods.